All-Extremity Exercise as a Novel Strategy for Optimizing Cardiovascular Function during Chemotherapy for Breast Cancer

ABSTRACT
Currently, there are 3.5 million breast cancer survivors in the United States and this number is expected to
increase dramatically. Early stage breast cancer survivors are more likely to die of cardiovascular disease (CVD)
than breast cancer. Exposure to chemotherapy may exacerbate existing CVD risk factors or may lead to acute
and long-term cardiovascular toxicity. Studies on the cardiovascular impact of chemotherapy have typically
focused on acute cardiotoxic effects. However, the vascular impact of chemotherapy, which may have longer
term consequences, is not well characterized. Recently, there is increasing evidence that chemotherapy may
cause endothelial dysfunction, a key early event in CVD development which leads to loss of atheroprotection
and independently predicts CVD events and progression. Therefore, strategies to prevent CVD in breast cancer
patients undergoing chemotherapy are clinically important. Aerobic exercise is considered safe during breast
cancer chemotherapy and may be an effective strategy for guarding against cardiovascular toxicity but there are
limited data in humans and no randomized controlled trials. Acute chemotherapy-induced side effects (e.g.,
fatigue, muscle weakness, balance problems, increased risk of falls) present unique challenges that may
influence the feasibility and tolerability of exercise, and in turn its efficacy. We have recently developed an all-
extremity non-weight-bearing exercise (ANE) intervention which is a promising novel and innovative exercise
approach for breast cancer patients during chemotherapy and may be superior to other widely recommended
forms of exercise. Our central hypothesis is that ANE will be feasible and will lead to greater cardiovascular
protection during breast cancer chemotherapy and will be better tolerated than walking. The aims of this
exploratory/developmental R21 application are to investigate in patients with primary non-metastatic breast
cancer who are undergoing chemotherapy: 1) the effect of ANE, treadmill exercise (TE) and usual care (UC) on
endothelial and cardiac function; and 2) the feasibility, tolerability and safety of ANE compared with TE. Breast
cancer patients will be randomly assigned to receive 12 weeks of supervised ANE, TE or UC during
chemotherapy. Exercise training will be supervised, and exercise prescription will be personalized to their initial
fitness level and will gradually progress to 70% of peak heart rate, 50 min/session, 3 days/week. The primary
focus will be on endothelial function assessed by brachial artery flow-mediated dilation via high-resolution
ultrasonography and global longitudinal strain assessed by speckle tracking echocardiography. Cardiovascular
assessments and other study measures will be completed before initiation of chemotherapy and after the
intervention. Feasibility, tolerability, and safety will be monitored throughout the intervention. This
exploratory/developmental R21 will provide early evidence on whether our promising ANE intervention
is feasible, more effective in mitigating cardiovascular toxicity and better tolerated than TE during breast
cancer chemotherapy. Our findings will lay the foundation for a Phase III clinical trial.

Public health relevance
NARRATIVE Currently, there are 3.5 million breast cancer survivors in the United States and this number is expected to increase dramatically. The proposed research will examine whether a novel exercise intervention for breast cancer patients who are undergoing chemotherapy protects against cardiovascular dysfunction. Findings may have implications for cardiovascular disease prevention in this population.